Metabolic reprogramming of the tumor microenvironment and therapy resistance

PROJECT SUMMARY/ABSTRACT
Metastatic ovarian cancer (OvCa) is the leading cause of death from gynecologic cancer. Despite aggressive
chemotherapy and surgery, most patients (80%) experience intraabdominal progression or recurrence to visceral
adipose tissue in the abdominal cavity. For more than 15 years, my laboratory has concentrated on elucidating
the biology of OvCa metastasis, focusing on understanding how deregulation of the tumor microenvironment
(TME) promotes OvCa metastasis and chemotherapy resistance. We defined the contribution of multiple stromal
cell types to metastasis, revealing a critical role for a methyltransferase (NNMT) in the reprogramming of normal
fibroblasts into cancer-associated fibroblasts through metabolic remodeling. Additionally, we answered the
decades-old question of why abdominally metastasizing tumors have a propensity to metastasize to the
omentum, finding that adipokines attract cancer cells to adipose tissue, and that adipocytes provide long-chain
fatty acids to cancer cells for energy production through β-oxidation. However, fundamental questions remain
about metabolic processes in OvCa progression. How are OvCa metastases metabolically different from primary
tumors? Which fuels/metabolites are altered after chemotherapy, and how do they contribute to chemotherapy
resistance? Given that immunotherapies are effective in several epithelial tumors, one of the more puzzling and
timely questions is why checkpoint inhibitors are ineffective in OvCa. My hypothesis is that cancer associated
adipocytes contribute to therapy resistance and immune effector cell exhaustion through the lipid-driven
metabolic reprogramming of the TME. We have adapted methods to perform in vivo metabolic flux analysis in
OvCa patients, by infusing labeled metabolites (non-radioactive 13C-glucose, acetate) and are working on
methods to optimize compartment resolved metabolomics on tumor tissue using imaging mass spectrometry.
These data will allow us to define metabolic changes in cancer, immune, and stromal cells before and after
neoadjuvant chemotherapy. The hypotheses generated by these studies will be tested with wide-ranging
experimental approaches using primary organotypic 3D cultures and mouse models. Our experimental approach
will span functional cellular assays (to study adhesion, migration, and invasion), confocal imaging, biochemical
activity assays, and newly devised methods to test the functionality of natural killer cells, T-cells, and
macrophages in vitro and in vivo. Compartment-specific insights into metabolic changes in the tumor organ will
be employed to develop high-throughout screening campaigns. These should discover small molecule inhibitors
that can be optimized through an established and structured process towards clinical testing. We believe that,
by targeting metabolic processes identified in the tumor organ, we can greatly enhance anti-tumor therapy
response in OvCa, potentially halting the inexorable progression characteristic of this deadly disease.

Public health relevance
PROJECT NARRATIVE Ovarian cancer most frequently metastasizes to the adipocyte-rich omentum and recurrences most frequently occur at adipose tissue depots. In this project, we will investigate the effect of metabolic reprogramming before and after chemotherapy on immune function and therapy response.